Delivery of Turtle Island Tales to Promote Family Wellness

PROJECT 2: PROJECT SUMMARY
American Indian (AI) communities experience profound health and economic inequities across the lifespan,
including increased risk for obesity, cancer, food insecurity (FI), and poverty. Overwhelming evidence indicates
obesity prevention evidence-based interventions (EBIs) reduce cancer risk, but the degree to which EBIs have
been developed in culturally relevant ways or to reach large numbers of AI families is extremely limited.
Community engaged dissemination and implementation (CEDI) strategies are needed across multiple social
ecological levels to increase EBI adoption, implementation, and maintenance in AI communities. Our objective
is to increase the reach of EBIs for cancer and obesity prevention among AI families who live in persistent
poverty areas (PPAs). The proposed project, Reach through Equitable Implementation of Turtle Island Tales in
AI Communities (REI-Turtle Island), is a participatory action research project designed to improve local
capacity for sustained EBI impact. Turtle Island Tales is a family-focused, home-based EBI for childhood
obesity prevention named to acknowledge Turtle Island as the term for North America used by many AI
communities. REI-Turtle Island will be conducted across four state Cooperative Extension Systems serving as
Supplemental Nutrition Assistance Program Education (SNAP-Ed) agencies in AI communities with ~4,000
children and their families in PPAs in rural and frontier areas. REI-Turtle Island engages system, community,
and organizational partners to identify, refine, and develop CEDI strategies to address both disease prevention
FI. A Project Steering Committee and Local Community Advisory Boards will conduct iterative planning and
evaluation using outcomes specified in the Reach, Effectiveness, Adoption, Implementation, and Maintenance
(RE-AIM) framework. For Aim 1, we will facilitate and evaluate the reach of T-Tales in PPAs within AI
communities in Montana, Oregon, South Dakota, and Wisconsin when delivered by Extension/SNAP-Ed;
determine the effectiveness of T-Tales for health behavior change, and evaluate the reduction in FI among
participating families by facilitating connections with community and system-level resources (e.g., SNAP,
WIC). For Aim 2, we will evaluate the state-level adoption, implementation, and organizational maintenance
capacity of Extension/SNAP and AI communities for T-Tales and determine budget impacts of implementing
T-Tales into sustained Extension/SNAP-Ed delivery. We expect to generate a novel CEDI Strategies Toolkit to
move obesity and cancer prevention EBIs into sustained community implementation and account for the
unique social and cultural contexts in AI communities in PPAs. Findings will advance the field of CEDI science
through the co-production of strategies to influence EBI adoption, implementation, and maintenance using an
innovative conceptual framework that leverages social ecological, dissemination and implementation,
behavioral, and health equity frameworks to prevent obesity and cancer in AI families in PPAs.